Cross validation of gene expression changes in C9orf72 FTD using Drosophila and human model systems

FTD is the second most common neurodegenerative dementia after Alzheimer’s disease (AD) in adults under
the age of 65. Pathologically, 45% of FTD cases are characterized by cytoplasmic protein aggregates
containing TAR DNA-binding protein 43 (TDP-43). Genetically, up to 43% of FTD patients have a family history
of dementia or related neurodegenerative diseases, with mutations in the C9orf72 (C9) gene representing the
most common genetic abnormality in FTD (10-30% of FTD cases). C9 mutations are expansions of GGGGCC
(G4C2) hexanucleotide repeats (HR) within its non-coding first intron. When affected by dementia, individuals
with C9 FTD most frequently show clinical features of behavioral variant (bv) FTD accompanied by memory
impairment. To begin addressing the mechanism of cognitive impairments in C9 FTD/ALS patients, the Sattler
group has recently used single nuclei RNA seq (snRNA seq) and, by comparing the transcriptomes of neuronal
nuclei containing TDP-43 associated cryptic exons (CEs) to those of nuclei containing canonical splice
junctions, identified significant changes in gene expression linked to TDP-43 pathology. Independently, using
RNA immunoprecipitations in a Drosophila model of dementia based on TDP-43 overexpression in mushroom
bodies (MBs), a neuronal circuit controlling dementia relevant behaviors, the Zarnescu group identified a
subset of TDP-43 candidate mRNA targets overlapping with differentially expressed genes in neuronal nuclei
with TDP-43 pathology in FTD patients, referred herein as “C9 FTD-TDP targets”. These findings led us to
hypothesize that “C9 FTD-TDP targets” mediate dementia relevant phenotypes in Drosophila models of
C9orf72 FTD and exhibit altered expression in FTD patient derived neurons and tissues. To test this
hypothesis we will cross-validate our C9 FTD-TDP targets between novel Drosophila models of dementia
based on G4C2 HRE expression in MBs and human experimental models including iPSC cortical neurons and
post-mortem tissues. First, we will use molecular and genetic approaches to identify C9 FTD-TDP targets that
are altered in Drosophila models of C9orf72 FTD and modify C9orf72 dependent axonal degeneration, polyGR
accumulation, working memory, sleep and lifespan. Second, we will validate C9 FTD-TDP targets in patient
cortical neurons and post-mortem tissues. These cross-validation experiments will identify physiologically
significant targets of G4C2 HR expansions in neurons and will highlight potentially novel therapeutic
approaches for C9 FTD.

Public health relevance
In this collaborative project we leverage snRNA seq data from FTD patients and Drosophila models of dementia to identify physiologically significant modifiers of G4C2 hexanucleotide repeat expansions toxicity in vivo in flies, as well as human ex vivo and in vitro model systems (postmortem brain tissue and patient-derived iPSC cortical neurons, respectively). Our results are poised to identify novel therapeutic targets for C9orf72 FTD.